Food Protection Rapid Response Team (RRT)

Food Protection Rapid Response Team (RTT) (U18) RFA-FD-15-020 Proposal Abstract The Washington State Department of Agriculture (WSDA) seeks funding from the U.S. Food and Drug Administration (FDA) under RFA-FD-15-020. Funding level requested is $600,000 over two years. While supporting the development of a nationally integrated food and feed safety system, the Washington State Department of Agriculture (WSDA) proposes to continue building capacity, experience, and networks to support the continued coordinated development and maintenance of the Washington Rapid Response Team (WA RRT). The WSDA has demonstrated continual growth and progress toward the purpose of the cooperative agreement. Some of these accomplishments include: • Developed a WSDA and FDA-endorsed operations manual for joint food/feed emergencies. • Coordinated multi-agency exercises to improve response efficiency. • Established inter-agency partnerships through outreach events, and joint trainings/exercises/information sharing. • Assisted in efforts to improve program infrastructure within the WSDA through the implementation of both the Manufactured Food Regulatory Program Standards (MFRPS) and Animal Feed Regulatory Program Standards (AFRPS). • Provided RRT development mentorship to the Iowa Department of Inspection and Appeals (DIA). The WSDA’s goals of this two year project are: • Expand food/feed emergency response capabilities through a team-building, collaborative, networking-rich approach including epidemiology, laboratory, and regulatory partners. • Continue to improve the ability of WA RRT response partners to implement ICS principles through trainings and exercises. • Address continual improvement through maintenance of the WA RRT Sustainability Plan and the Washington RRT Improvement Plan. The WSDA meets all eligibility requirements for this funding opportunity, including: • Maintains current contract with FDA for food safety inspections. • Currently enrolled in MFRPS and AFRPS. • Currently receiving funding under the Food Protection RRT Cooperative Agreement awarded under RFA-FD-13-006.

Public health relevance
Food Protection Rapid Response Team (RTT) (U18) RFA-FD-15-020 Project Narrative The Washington State Department of Agriculture (WSDA) carries out a broad spectrum of activities to support all levels of the farm-to-fork continuum within the state’s diverse agricultural economy. Through partnerships and perseverance, the agency continues its one hundred and three year-mission to protect consumers by ensuring a safe supply of quality foods and feeds. The WSDA Food Safety and Consumer Services (FSCS) Division protects public health by licensing, conducting inspections, and collecting samples at food and feed facilities while providing food safety technical assistance to the food and feed industry. Housed within FSCS, the WSDA Microbiology Laboratory serves as a lead state laboratory for conducting routine surveillance for food and feed products. The laboratory also provides surge capacity to meet the needs of the WSDA and its partners during food and feed emergency responses. The WSDA is willing and able to participate in the following project areas, including but not limited to:  Maintaining ISO/IEC 17025:2005 accreditation, fully participating in FERN activities, sharing data through eLEXNET, and providing mentorship to other labs.  Continuing to participate in the MFRPS and AFRPS cooperative agreements.  Building working relationships among food and feed safety partners through the Washington Rapid Response Team’s (WA RRT) involvement in the implementation of the Washington State Food Protection Task Force (FPTF) cooperative agreement.  Improving emergency response capability and capacity within the WA RRT, WSDA and on the national front to further the development of a nationally integrated food and feed safety system.